Functional identification of non-coding variants associated with metabolic dysfunction-associated steatotic liver disease

Abstract/Project Summary
Metabolic dysfunction-associated steatotic liver disease (MASLD) typically initiates as a benign and reversible
condition. However, a subgroup of MASLD patients progresses to a severe stage known as metabolic
dysfunction-associated steatohepatitis (MASH), often leading to hepatocellular carcinoma and liver failure.
Given the global prevalence of MASLD, the significant heterogeneity among patients emphasizes the necessity
to efficiently allocate medical resources by identifying those at high risk. Like many other complex diseases,
MASLD's occurrence and progression stem from a combination of genetic background and environmental
factors. Although genome-wide association studies (GWAS) have identified numerous genetic variants
associated with MASLD, their causality and functional roles, especially in non-coding regions, remain largely
unexplored. To bridge this gap, we curated a list of non-coding variants from GWAS and prioritized them based
on cis-regulatory activity. Integrating in vitro and in vivo analyses of cis-regulatory activity led to the
identification of potentially functional regulatory variants (FrVar), hypothesized to predict MASLD genetic risk.
Leveraging the Candidate's expertise in functional genomics and bioinformatics, the proposed research aims
to elucidate the cis-regulatory function of FrVar in a cell-type-specific manner by manipulating their activity in
iPSC-derived liver cells and organoids (Aim 1). Furthermore, the study will investigate alterations in
transcription factor binding by FrVar, with a particular focus on EGR1, in iPSC-derived liver cultures modeling
MASLD/MASH (Aim 2). Finally, to comprehensively evaluate the clinical value of FrVar, polygenic risk scores
will be constructed and their predictive power assessed using biobank data (Aim 3). These endeavors seek to
unravel the molecular mechanisms and translational values of non-coding variants in MASLD onset and
progression, offering insights into patient risk stratification and management. The accomplishment of these
objectives will enhance the Candidate's growth in MASLD studies, emphasizing a stronger focus on human
relevance. This proposal will also facilitate the Candidate's professional development in laboratory
management and leadership, thereby establishing a solid foundation for an independent research program in
the MASLD field.

Public health relevance
Project Narrative While metabolic dysfunction-associated steatotic liver disease (MASLD) prevails worldwide, the huge heterogeneity among patients underscores the urgency of identifying those at high risk to efficiently allocate medical resources. Despite numerous genetic variants associated with MASLD risk have been identified through genome-wide association studies (GWAS), their function and causality are largely unknown. In this proposal, my goal is to investigate non-coding variants pertaining to the molecular mechanisms of transcriptional regulation, as well as their clinical potential in predicting MASLD risk.